TFH cell programming for IgE responses

Allergic disease greatly impacts the quality of life in the United States and costs billions of dollars
annually on health care and lost productivity. IgE is the primary mediator for the immediate hypersensitivity
phase of the allergic response and can also drive life-threatening anaphylaxis. Allergen-specific IgE is
produced in germinal center (GC) reactions and requires help from IL-4-secreting T follicular helper (TFH)
cells. TFH cells localize to the GC, where they promote B cell clonal expansion and antibody affinity
maturation. A major unresolved question is what factors control the development of TFH cells that promote IgE
responses. High affinity IgE antibodies are formed in allergic responses which involve the development of IL-4-
expressing TH2 cells and IL-4-expressing TFH cells (sometimes referred to as TFH2 cells). However, the
developmental connection between TH2 cells generated in allergic responses and TFH2 cells is unresolved.
Additionally, IL-4-expressing TFH cells can develop without the production of significant IgE responses.
In a recent study, using a food allergy priming model in mice, we characterized TFH cells that
developed under two different methods of priming using the same allergen and adjuvant, but varying in the
timing of the priming. We analyzed the TFH cells that developed under these two conditions and identified
significant differences in gene expression. In both priming conditions, IL-4-expressing TFH cells developed, but
IgE responses only developed in only one priming condition. We termed the TFH cells that promote IgE in this
system as TFH-IgE cells, to distinguish them from TFH2 cells.
Our goal in this application is to define the requirements for TFH-IgE cell development. We have found
that Anxa1, a regulatory gene which is a known inhibitor of TH2 and IgE responses, is strongly down-regulated
in TFH-IgE cells compared to TFH2 cells. The role of Anxa1 in TFH cell function has not been previously
explored, however new findings reveal that Anxa1 expression is down-regulated by IL-4 signaling in activated
CD4 T cells. We therefore hypothesize that Anxa1 is a signal modulating protein that inhibits the development
of TFH-IgE cells, and that, in contrast to TFH2 cells, TFH-IgE cells are generated by IL-4-Stat6 signals which
critically down-regulate Anxa1 expression to allow full TFH-IgE differentiation (characterized by increased IL-4,
CD40L; decreased Fgl2 and Entpd1).

Public health relevance
We have discovered a new T cell subset, TFH-IgE cells, that are a key regulator of the allergic immune response and IgE, but much is unknown about how these cells are regulated. These studies will find pathways that control TFH-IgE cells and may lead to new therapies for the treatment of allergic diseases such as asthma and food allergy.